Evaluation of Project Empowerment Navigation Services for medical engagement of African American Clients living with and at risk for HIV

PROJECT SUMMARY
Project Empowerment: Patient Navigation and Contingency Management Intervention
We plan to evaluate the effectiveness of Charles R. Drew University’s (CDU) Project
Empowerment navigation intervention which is a 12-month evidenced-based clinical intervention
utilizing enhanced patient navigation services to address barriers causing disparities in HIV care
and prevention among African Americans at Martin Luther King OASIS Medical Clinic, our
community partner. The intervention offers personalized support through patient navigators (PN)
to increase health literacy and to identify barriers affecting social determinants of health. This
study will pair the intervention with the use of contingency management incentives in order to
improve client outcomes. The specific aims of the study are to demonstrate the effectiveness of
patient navigation and contingency management to: reduce client barriers, engage/retain
clients in care, increase linkage to clinical care services, increase adherence to ART/PrEP,
improve viral load suppression, reduce HIV transmission, and improve HIV outcomes among
Blacks/African Americans. This project uses multi-level approaches as defined in the NIMHD
Sexual & Gender Minority Health Disparities Research Framework. Surveying and evaluation
will track measures of Social Determinants of Health identified in the PhenX Toolkit.

Public health relevance
Project Narrative Ending the HIV Epidemic in the United States depends on effective strategies that target populations with highest disparities in HIV care. Funding from this grant will support evaluation of patient navigation coupled with contingency management to improve outcomes for African Americans, the group with the highest rate of HIV diagnoses in Los Angeles County.